Brain-enriched microRNAs detectable in plasma as biomarkers of Alzheimer's Disease

SUMMARY
One in 10 Americans aged 65 and older have Alzheimer’s disease (AD). Since AD begins with a prolonged, over
10 year-long, asymptomatic stage, a growing number of companies are developing new therapies that aim to
intervene early in the progression of AD and related forms of dementia. There is thus a great need for minimally
invasive diagnostic tools for primary screening of individuals with early stages of the disease. DiamiR has
developed a platform technology for detection, prognosis, and monitoring of different stages (from the preclinical
stage to dementia) of AD based on targeted selection and analysis of brain-enriched and inflammation-
associated microRNAs (miRNAs) circulating in blood plasma. Working with leading academic Alzheimer’s
Disease Centers, DiamiR has produced a large amount of data, which supports the use of miRNA biomarkers
for detection of AD at different stages of the disease. This data include detection of clinically diagnosed mild
cognitive impairment (MCI) with accuracy of 95%, differentiation of AD from other neurodegenerative diseases
with ≥80% accuracy, and identification of cognitively normal subjects who would later progress to MCI with 75%
accuracy. Based on an analysis of over 1,000 well-characterized plasma samples, we defined 24 miRNAs for a
diagnostic test, CogniMIRTM. The objective of the current Commercialization Readiness Program (CRP) is to
develop a clinic-ready lab-developed test (LDT) compliant with Clinical Laboratory Improvement Amendments
(CLIA) guidelines for detection of preclinical AD, MCI, and AD. In the ongoing Phase IIB study, we worked with
the Roskamp Institute and Thermo Fisher Scientific to analyze multiple pre-analytical factors in order to minimize
variability and increase sensitivity and reproducibility of the assay. We optimized the protocol for blood collection,
plasma preparation, and miRNA extraction. Further, we have developed a detailed workflow for the analysis of
24-miRNA classifier. In the present CRP project, in partnership with Interpace Biosciences we will finalize assay
protocol for the clinical setting and implement the test in a CLIA-compliant laboratory. Following analytical
validation, we will perform a multi-center double-blinded cross-sectional clinical study to assess test performance
for detection of preclinical AD, MCI, and AD among representative elderly subjects seen at geographically
diverse Alzheimer’s Disease Centers in the US. Provided the project is successful, the new LDT comprising
CogniMIRTM could be immediately used to help screen patients for MCI/AD clinical trials. Once the CogniMIRTM
test is validated with 15,000-20,000 patient samples from heterogeneous cohorts, we will broadly launch the test
to gerontologists/neurologists and other medical professionals engaged in AD treatment and care.

Public health relevance
NARRATIVE In this Commercialization Readiness Program, DiamiR will complete the development and validation of CogniMIRTM, a blood-based diagnostic test for screening early stage Alzheimer’s patients for clinical trials. The test is based on measuring plasma levels of microRNA molecules enriched in specific brain regions affected by the disease. The project builds on a large body of prior work that supports the feasibility of the diagnostic technology and the utility of the selected microRNAs as biomarkers of Alzheimer’s disease.